Emergent mechanics of mammalian chromosome segregation

Project Summary/Abstract
Every time a cell divides, it must accurately segregate its chromosomes for daughter cells to inherit an intact
genome. The spindle and kinetochore are the large cellular machines that drive this segregation, and their
failures can give rise to birth defects and cancer. In mammals, we now have a near complete list of these
machines’ molecules, and know much about their biochemistry and structure. Yet, despite the spindle and
kinetochore playing an essential physical role – moving chromosomes – how their molecules give rise to their
emergent physical properties and function remains poorly understood. In large part, this is because of the
challenges of working with large cellular machines vitro, and of probing mechanics in vivo. To meet this
challenge, our lab set out to bring controlled mechanical perturbations inside dividing mammalian cells, and to
combine them with precise molecular ones. Key to our efforts, we can now use microneedle manipulation to
exert local, controlled forces in dividing mammalian cells. We combine physical and molecular perturbations of
live cells with imaging, modeling and in vitro work to ask: How do many thousands of nm-scale molecules
generating force give rise to the µm-scale spindle’s architecture, mechanics and dynamics, which together
drive its function? How do thousands of kinetochore molecules work together to robustly slide on yet grip
microtubules, and to monitor physical attachment signals to control attachment stability and cell cycle
progression? These are the questions we seek to answer.
Our recent progress towards this goal helps motivate our future work. On the spindle front, our recent
work helps us understand how opposing forces are balanced and their function in the spindle, and the role of
local reinforcement and isolation in maintaining global spindle structure. We now seek to define the
mechanisms and functions of the spindle’s largely achiral structure given its chiral motors, of its local
heterogeneous mechanics, and of its remodeling under force to both preserve and transform its structure
during mitosis. On the kinetochore front, our recent work provides insight into how low friction elements help
kinetochores slide on yet grip microtubules, and into the physical cues the error correction and spindle
assembly checkpoint monitor for decision-making. We now seek to understand how mechanical heterogeneity
of kinetochore molecules gives rise to a robust grip, and how chromosome size impacts the physical cues
monitored for error correction and spindle assembly checkpoint satisfaction, and their implications.
Our long-term goal is to uncover the basic physical design principles of robust and accurate
mammalian chromosome segregation. We believe that working on the spindle and kinetochore together
provides conceptual and technical synergy not possible by studying them separately. More broadly, we expect
that our work will in the long run help us understand how ensembles of molecules give rise to the physical
properties and functions of other large and complex cellular machines.

Public health relevance
Project Narrative During cell division, each daughter cell must inherit one copy of each chromosome as errors can lead to birth defects and cancer. The spindle and kinetochore are the two large cellular machines responsible for segregating chromosomes. Here we probe how these machines work, with the goal of uncovering the mechanical design principles driving accurate chromosome segregation and ultimately helping us target dividing cells for therapy.